Administration Core

The Indiana Center for Musculoskeletal Health (ICMH) Clinical Research Center (ICMH-CRC) will serve as the
cornerstone for clinical research conducted in the ICMH. The mission of the ICMH-CRC is to promote and
advance clinical research in musculoskeletal (MSK) disorders leading to prevention, diagnosis, treatment and
cure for ALL individuals. The overall goal of this P30 application is to provide the needed infrastructure and
training to enhance clinical and translational research in MSK disorders through the use of state of the art
technologies that connect phenotypes to comprehensively evaluate factors that contribute to poor MSK health.
The Specific Aim of the Administrative Core is to facilitate cross disciplinary clinical research. The Administrative
Core will focus on the following Goals: Goal 1) The Administrative Core will provide overall administrative support
and periodic review to the MSK-Methodology and MSK-Resource Cores, including budget oversight,
coordination of scientific and project meetings, and tracking of users, grants and publications and serve as the
liaison to investigators, collaborators, Advisory Boards, NIH-NIAMS, and external academic and industry
collaborators. Goal 2) The Administrative Core will lead internal communication by providing advice and direction
for the enhancement of clinical research in MSK disorders through individual consultation, engagement with
Thematic Teams, and presentations and organization of symposiums and workshops. The Administrative core
will lead external communication and outreach efforts by promoting the use of our cores and the addition of end
points of MSK health in prospective trials or cohort studies of chronic disease, raise awareness and educate
health care professionals and laypersons, and coordinate with the CTSI Community Health Engagement
Program to enhance community engagement with racially and ethnically diverse populations to encourage
participation in MSK research. Goal 3) The Administrative Core will administer a pilot grant program to encourage
use of cores. Goal 4) The Administrative Core will coordinate a clinical rotation for all learners (students,
residents, fellows, and MSK PhD students) that demonstrates the broad clinical field of MSK health and
coordinate with the CTSI Clinical Research Center to ensure exposure to MSK research for physician residents
and fellows.